Impact of the expiration of temporary pandemic SNAP benefits on the healthfulness of supermarket food purchases

PROJECT SUMMARY
The Supplemental Nutrition Assistance Program (SNAP) is the largest food security program for lower-income
households in the U.S., providing financial benefits for grocery purchases to nearly 42 million people (1 in 8).
SNAP benefit amounts increased substantially starting in March 2020, most of which was driven by temporary
emergency allotments (i.e., supplemental benefits), to bolster food security in response to the COVID-19
pandemic and to ensure participants could afford a healthy diet. These emergency benefits expired across all
states in March 2023, a policy that is estimated to have reduced benefits by an average of $175 per household,
a ~33% decline. The sudden end of SNAP emergency allotments represents the largest-ever universal reduction
in SNAP benefits and could have a major impact on households’ food purchases and their subsequent health.
However, this has not been investigated to date. This study will make a significant contribution by evaluating the
impact of the expiration of SNAP emergency allotments on participants’ food purchase quality overall, among
historically underserved groups with worse food access and pre-pandemic inequities in nutrition-related chronic
disease, and in the context of concurrent economic, social, community, and retail factors. We will use a mixed-
methods approach that combines a natural experiment of household purchases with qualitative interviews of
SNAP participants and those working in the larger food system. In Aim 1, we will analyze longitudinal, loyalty-
linked sales data on >440,000 customers of a large Northeast supermarket chain who made purchases from
November 2021-February 2023 (16 months before the end of SNAP emergency allotments). We will use
controlled interrupted time series (CITS), a quasi-experimental method, to estimate the effect of the end of SNAP
emergency allotments on several indices of food purchase quality from April 2023-March 2024 (12 months after
the end of allotments) among SNAP-participating households (intervention) vs. non-participating households
(control). In Aim 2, we will enroll a cohort of 2,500 lower-income shoppers who shop at the chain and whose
purchases can be identified by loyalty number. We will assess household-level data via online surveys and use
CITS to examine associations between the end of SNAP emergency allotments and supermarket food purchase
quality by rurality, race/ethnicity, and economic stability. In Aim 3, we will explore individual-level factors (e.g.,
use of other assistance programs, cooking norms, food preferences) by conducting semi-structured qualitative
interviews among 45-75 participants from the cohort in Aim 2 who participate in SNAP and represent rural, Black,
and Hispanic demographic segments of the study population. We will explore system-level factors (e.g., food
availability, supply chains, pandemic era SNAP policy rollout) via interviews with representatives from SNAP
implementing agencies, supermarket retailers, and food pantries from within each of the communities of interest.
This research will generate timely, rigorous evidence on the nutritional impact of this substantial change to SNAP
benefits, which will be useful to policymakers to help guide future program changes.

Public health relevance
PROJECT NARRATIVE Temporary, pandemic-related emergency allotments for the Supplemental Nutrition Assistance Program (SNAP) ended universally in March 2023, leading to a major decline in benefits for participants. This policy could have a large impact on participating households’ food purchase quality, especially for historically underserved populations with worse food access and pre-pandemic inequities in nutrition-related chronic disease. This project will evaluate the effects of the expiration of SNAP emergency allotments on the healthfulness of participant food purchases, identify potential inequities in these effects by rurality, race/ethnicity, and economic stability, and explore how concurrent economic, social, community, and retail factors influenced food choice after this policy change.